Does Tobacco Social Media Marketing Alter Adolescent Risk Perceptions and Use? Longitudinal Data-Adaptive Estimators and Causal Inference to Enhance Understanding

Project Summary
Youth trajectories of tobacco use are of critical importance in the future of public health. Most tobacco
use begins in adolescence and adolescents are particularly vulnerable to long-term tobacco use. While
cigarette smoking significantly declined among adolescents over the past decade, overall tobacco/nicotine use
actually increased by some measures, primarily due to increased rates of use of electronic nicotine delivery
systems (ENDS). These changes in population levels of adolescent tobacco use are of critical importance in
predicting tobacco control challenges and opportunities in the next decade. As the scientific debate unfolds
regarding ENDS health effects, adolescents nationwide are learning about tobacco products and attempting to
rectify conflicting information to create and refine their own beliefs regarding these products.
At the same time, youth are increasingly living their lives filtered through social media account
participation. Marketers are well aware of this fact and act to influence youth to purchase their products.
Tobacco marketers are certainly no exception. Social media marketing is particularly important to examine as it
is a prevalent source of adolescent exposure that is amenable to policy change. Social media marketing differs
from other forms of marketing in that it exploits participatory facilitation, algorithmic coordination, context-
specific promotions, real-world enmeshment, and seamless integration with purchasing opportunities. Although
some research has examined this issue, there are important methodological concerns that may lead to flawed
or incomplete understanding of the relationships involved and hinder the development of policies or other
approaches to reduce the influence of social media marketing on youth ENDS use. We will address limitations
in prior research by using both longitudinal data-adaptive, semiparametric estimators and a causal inference
approach. We will focus on two risk perceptions: harmfulness and addictiveness. The degree to which risk
beliefs act as mediators of the effects of social media marketing on use is unclear. Effective ENDS control
strategies for adolescents require a more comprehensive understanding of how attitudes change over time and
the potential impact of social media marketing on these changes
The Population Assessment of Tobacco and Health (PATH) dataset provides a unique opportunity to
examine youth beliefs about tobacco products, marketing exposure, and patterns of tobacco use among
adolescents in the United States longitudinally. The current study will examine underutilized, recent Waves to
examine the impact of online ENDS marketing on use with longitudinal data-adaptive, semiparametric
estimators and to examine risk perceptions as potential mediators explaining the effects of adolescent
marketing exposure on ENDS use with a causal inference approach.

Public health relevance
Project Narrative Youth are increasingly living their lives filtered through social media account participation—a setting where marketers are constantly innovating to gain youth attention and influence. Effective e-cigarette control strategies for adolescents require a more comprehensive understanding of the potential impact of social media marketing on their attitudes and use. The current project will use state-of-the-art techniques to examine these questions and thereby increase the ability of public health officials and policymakers to develop appropriate countermeasures.